ERK signaling in arteriogenesis

The development and formation of normal and abnormal
vasculature is of critical importance to both normal biology and disease pathogenesis. Vascular
homeostasis plays an important role in maintenance of normal vessel and organ function. Recent
studies from our and other laboratories have established that ERK1/2 (extracellular receptor kinases 1
and 2) are critical to these processes. Yet there is a very limited understanding of what these kinases
do and how this is accomplished. We propose to determine relative contributions of ERK1 vs. ERK2 to
arterial fate specification and arteriogenesis, establish key steps in regulation of the ERK activity,
discovery downstream signaling pathways, and decipher functional effects of ERK1 vs. ERK2 signaling.
In preliminary studies we have observed abnormal arteriogenesis in mice missing the ERK1 isoform
and abnormal angiogenesis in mice missing the ERK2 isoform. These data point to unexpected
specificity of these kinases’ activity that open a possibility of selectively targeting these two processes.
The ability to do so would be of tremendous clinical significance.

Public health relevance
Coronary artery disease and peripheral artery disease are major causes of illness and death in developed nations. Poor arteriogenesis is a critical determinant of these diseases and in patients’ recovery after myocardial infarction. This PPG proposes to elucidate mechanism controlling blood vessel growth with the aims towards developing new therapeutic modalities for treatment of these diseases. These studies have the potential to identify new targets and new reagents for therapy, as well as to achieve a deeper understanding of the biology of arteriogenesis.